THE IMPORTANCE OF MACROPHAGE SENESCENCE IN REGULATING ANGIOGENESIS IN THE EYE

DESCRIPTION (provided by applicant): The macrophage is a key component of the innate arm of immunity and is critical in regulating initial immune response to tumors, infections and in inflammation. The macrophage is also a central player in sustaining immune privilege in the eye. Immunosenescence is characterized by age-related changes in both the innate and adaptive compartments of the immune system. Innate immunity, specifically macrophage function, has received particular attention in the eye as it can modulate developmental and post-developmental angiogenesis. Ocular neovascularization plays a central role in visual impairment and blindness in several disease states of the eye, including age-related macular degeneration, diabetic retinopathy, retinopathy of prematurity, and intraocular tumors. The work described in this proposal will help elucidate the mechanisms by which senescence induces a functional drift in macrophages towards a deleterious pro-angiogenic phenotype. Our studies will also test how altering macrophage polarization determines angiogenic fate in the eye. These questions are especially relevant to the importance of macrophages in AMD. These goals will be accomplished by: a) Quantifying age-related changes in IL-10 activated signaling pathways in macrophages that lead to loss of anti-angiogenic function and b) Demonstrating that abnormal processing of cholesterol, a dominant component of drusen, causes old macrophages to become pro- angiogenic.

Public health relevance
Public Health Relevance: Angioproliferative eye diseases account for a significant majority of blindness burden across all age groups. Mechanisms that lead to immune dysfunction as identified in this proposal that are relevant to the pathophysiology of abnormal angiogenesis will help us devise immune based therapies that ameliorate disease progression and ultimately blindness. PUBLIC HEALTH RELEVANCE: Immune cells and cytokines secreted by immune cells, specifically macrophages, are emerging as central players in regulating eye diseases associated with abnormal blood vessel growth. These include age-related macular degeneration, retinopathy of prematurity, and diabetic retinopathy. We aim to understand the mechanisms by which macrophage dysfunction promotes disease progression and hope to provide new insights in order to design future therapies to prevent blindness from these diseases. Project Narrative Immune cells and cytokines secreted by immune cells, specifically macrophages, are emerging as central players in regulating eye diseases associated with abnormal blood vessel growth. These include age-related macular degeneration, retinopathy of prematurity, and diabetic retinopathy. We aim to understand the mechanisms by which macrophage dysfunction promotes disease progression and hope to provide new insights in order to design future therapies to prevent blindness from these diseases. __SpecificAimsTextDelimiter__ 2. Specific Aims AMD is the leading cause of blindness in the elderly in the developed world. Dry AMD, characterized by deposition of cholesterol containing drusen, accounts for a large portion of the disease prevalence but the majority of blindness is caused by wet AMD, marked by the development of abnormal blood vessels called choroidal neovascularization (CNV). Macrophages are critically important in regulating CNV. Although we have shown that interleukin-10 (IL-10) levels increase in the aging eye and polarize macrophages away from an anti-angiogenic M1 phenotype to a pro-angiogenic M2 phenotype, age-related programmatic changes within the macrophage that alter responsiveness to IL-10 are still unknown. It is also unclear how cholesterol within drusen influences macrophage function. Progressive accumulation of drusen in the sub-retinal space is a potential nidus for pro-angiogenic inflammation in the aged eye. The ultimate goal of our research is to understand how aging affects the ability of macrophages to regulate CNV. This proposal focuses on intrinsic changes in the aged macrophage that affect its response to two environmental signals that promote pro- angiogenic behavior a) IL-10, and b) Cholesterol. We hypothesize that 1) pro-angiogenic behavior of aged macrophages is associated with differential responsiveness to the IL-10 signal, and that 2) aged macrophages encounter and are unable to process progressively increasing amounts of drusen associated cholesterol that polarizes macrophages to a pro-angiogenic M2 phenotype. We will address these questions in the following specific aims: 1. Quantify age-related changes in IL-10 activated signaling pathways in macrophages that lead to loss of anti-angiogenic function. A key cytokine that causes macrophages to become pro-angiogenic is IL-10. We hypothesize that IL-10 differentially activates critical signaling molecules NF-κB and stat-3 in aged macrophages vs. their young counterparts. Aberrant activation leads to abnormal gene expression and pro-angiogenic M2 polarization. We will use pharmacologic and genetic approaches to test this hypothesis: 1-i) Young and old macrophages will be tested at baseline and in IL-10 enriched environments for the activation of NF-κB and/or stat-3. We hypothesize that activation of signaling intermediates NF-κB and stat- 3 within the macrophage is critical to their ultimate fate i.e. polarization to the M2 anti-angiogenic phenotype. We also hypothesize that programmatic changes in old macrophages make them prone to the M2 phenotype at baseline and hyper-responsive to IL-10 activation. 1-ii) Effect of IL-10 on the cytokine profile of macrophages deficient in stat-3 or NF-κB function will be examined by gene expression and multiplex protein analysis. We predict that IL-10 will be unable to polarize NF-κB or stat-3 deficient macrophages to an M2 phenotype. 1-iii) Functional significance of the differences in activation of signaling pathways between young and old macrophages on angiogenesis will be tested in vitro using vascular endothelial cell proliferation assays and in vivo by measuring CNV. These experiments will reveal the contribution of individual components of IL-10 activated signaling pathways to the pro-angiogenic behavior of old macrophages. 2. Demonstrate that abnormal processing of cholesterol causes old macrophages to become pro- angiogenic. AMD is characterized by the deposition of cholesterol rich drusen underneath the retina. Drusen, which contain esterified and unesterified cholesterol, precede the development of CNV and are thought to be chronic stimuli for the eventual development of neovascular AMD. Based on our preliminary observations, we hypothesize that aged macrophages are unable to process cholesterol efficiently. We will test the hypothesis that a larger cholesterol load in the lysosomal compartment of old macrophages will induce programmatic changes that lead to the development of a pro-angiogenic M2 phenotype. We will use morphologic, functional, and genetic approaches to test this hypothesis: 2-i) Ability of young macrophages to process cholesterol will be compared to that of old macrophages by confocal imaging, electron microscopy, and flow cytometry. The effects of age on lysosomal function, cholesterol influx, and efflux pathways will be studied. 2-ii) Downstream effects of cholesterol accumulation and lysosomal dysfunction will be studied by analyzing the gene expression and secretion of M1/M2 polarizing cytokines and surface Fas Ligand (FasL) by quantitative real time PCR, flow cytometry for surface FasL, and quantitative multiplex protein arrays. The effects on angiogenesis will be studied in vitro and in vivo.